FILTRATION OF CHOLESTEROL IN VIVO FROM HUMAN SUBJECTS

Some human subjects have extremely high levels of cholesterol and an experimental protocol has been devised to filter out large amounts of cholesterol using a commercial cell separator followed by filtration of the plasma and re-injection of the plasma into the subject.